Developing therapeutic antibodies for Alzheimer's disease

PROJECT SUMMARY/ABSTRACT
Millions of Americans suffer from Alzheimer’s disease and there are currently no therapies available to
prevent or slow the progression of the disease. The unmet medical needs of individuals with Alzheimer’s disease
result in hundreds of billions of dollars of costs in paid and unpaid caregiving in the United States every year.
VersaPeutics is a small business developing novel therapeutics for Alzheimer’s disease. In this Phase I SBIR
project we will perform IND enabling preclinical studies to investigate pharmacokinetics and pharmacology
profiles of leading drug product. At the conclusion of these studies, we will have met several important milestones
that will support further preclinical development of our novel therapeutics for Alzheimer’s disease.

Public health relevance
NARRATIVE We are developing novel antibodies that we hypothesize will be therapeutic for individuals with Alzheimer’s disease.